The Effects of Prenatal Thirdhand E-cigarette Exposure on Platelets

While smoking has been on the decline, e-cigarette usage has been on the rise; especially in vulnerable
populations. Furthermore, even though the contribution of in utero third-hand smoke (THS) and e-cigarettes to
the pathogenesis of thrombotic diseases have recently been documented, the involvement of in utero third-hand
e-cigarettes (IUTHEC) in such disease processes remains unknown. Consequently, the present application
outlines studies that address fundamental, mechanistic, and clinically-relevant translational aspects of the
adverse-health effects of IUTHEC, in the context of thrombotic disease and platelet biology, and in a device-, e-
liquid-, and sex-specific manner. These studies are of paramount significance given the “perceived safety” of e-
cigarettes, and will be conducted using a novel/new IUTHEC exposure model. The Aims of this proposal are:
Aim 1. Investigate the impact of IUTHEC exposure on platelet-dependent disease states. While there is
compelling evidence that e-cigarettes and in utero THS do exert negative health effects, the impact of IUTHEC
on platelet-dependent diseases is still unknown. To address this issue, the consequences of IUTHEC exposure
on normal hemostasis and platelet counts will be determined. Subsequent studies will examine whether IUTHEC
participates in the development of thrombosis-based disease. Finally, the effects of IUTHEC on plasma
“markers” of thrombosis will also be determined. Notably, experiments will be designed in a manner that
addresses the role of the device, and e-liquid in mediating the “platelet”-dependent negative effects of IUTHEC.
Furthermore, the preliminary data does show, for the first time, that IUTHEC, in utero THS and e-cigarettes
increase the risk of thrombotic cardiovascular disease.
Aim 2. Investigate the mechanism by which IUTHEC exposure modulates platelet function. Even though
published data indicate that in utero THS and e-cigarettes modulate platelet activation, whether IUTHEC
produces similar effects (i.e., the mechanism by which it modulates platelet function) remains to be investigated.
Thus, the overall goal of the mechanistic experiments proposed in this section is to determine the impact of
IUTHEC exposure on the various platelet functional responses (e.g., GPIIb-IIIa activation), thromboxane A2
levels, biochemical “markers” of platelet activation, as well as assess the contribution of other blood cells (e.g.,
neutrophils) and alterations in the platelet epigenetics to the IUTHEC phenotype.
Collectively, these experiments will make significant contributions to the understanding of the
consequences of IUTHEC/e-cigarettes on platelet activation and cardiovascular human health, and the
mechanism by/through which it exerts these effects, in a device-, e-liquid-, and sex-specific manner.

Public health relevance
Collectively, the studies proposed in the presented application, some of which are translational in nature, address mechanistic and fundamental concerns pertaining to the cardiovascular health effects of in utero exposure to thirdhand electronic-cigarettes, an increasingly popular form of tobacco and an underappreciated form of exposure, by employing a systematic platelet function and related animal model and disease analysis approach, in the context of gender. Findings from these studies should lay the foundation not only for understanding, and advancing policy and means for evidence-based therapeutic management, but also for the prevention and control efforts of e-cigarette/tobacco-associated thrombotic disorders.